Harnessing ecDNA Detection in Antigen-Presenting Cells for Anti-Tumor Immunity

PROJECT SUMMARY
Despite dozens of agents targeting the myeloid checkpoint CD47 entering clinical trials, their variable tumor-
type impact has spurred a search for complementary biologics to augment tumor inflammation. Antitumor
immune responses in antigen-presenting cells (APCs) are catalyzed by the engulfment of tumor cells and the
recognition of tumor-derived DNA by cytoplasmic nucleic acid sensors. Nevertheless, these immunogenic
processes are hindered by phagocytic checkpoints and inefficient translocation of nucleic acids from
phagolysosomes into the cytosol. Cytoplasmic extrachromosomal DNA (ecDNA) functions as a potent innate
immunostimulant. However, no therapeutic strategies specifically target phagolysosomal release of ecDNA or
other tumor-derived contents within professional APCs. To overcome these challenges, we recently
engineered an antibody-drug conjugate (ADC) that targets the “don’t eat me” signal CD47 linked to the
bacterial toxin listeriolysin O from the intracellular bacterium Listeria monocytogenes via a cleavable linker
(CD47-LLO). CD47-LLO promotes the phagocytosis of cancer cells followed by the activation of LLO which
disrupts phagolysosomal membranes and allows for cytosolic escape of tumor-derived contents in APCs. The
current proposal explores the use of CD47-LLO to promote antitumor immune responses against recalcitrant
tumor types that produce high levels of ecDNA. Aim 1 of the proposal will mechanistically examine how ecDNA
detection in APCs triggers potent and broad antitumor signaling pathways. For Aim 2, we will examine how
phagolysosomal release of ecDNA stimulates both innate and adaptive immune responses. Finally, for Aim 3,
we will evaluate the antitumor effect of CD47-LLO in combination with frontline therapies in animals bearing
gliomas or colorectal cancers with high ecDNA expression. If successful, this proposal will support bench-to-
bedside translation of an immunostimulatory ADC with potential to destroy diverse cancers that harness
ecDNA for survival. This research will be performed by Dr. Benjamin Schrank, a radiation oncologist at the
University of Texas MD Anderson Cancer Center. Dr. Schrank will be advised by a multidisciplinary mentoring
team consisting of physician-scientists, oncologists, immunologists, and tumor biologists. His primary mentor,
Dr. Wen Jiang, is a recognized expert in cancer nanomedicine; his co-mentor, Dr. Betty Kim is known for her
neurosurgical and preclinical work on glioblastoma. They will be joined by Dr. Linghua Wang, a pioneer in
tumor immunology and spatial transcriptomics; Dr. Jian Hu, a leader in cancer neuroscience; and Dr. Michael
Curran, an internationally recognized cancer immunotherapy expert. MD Anderson provides an outstanding
environment for Dr. Schrank’s career development. Resources and equipment critical to the proposed research
are readily available on campus. Together, the proposed research, training, and career development plan will
provide Dr. Schrank with the expertise needed to achieve independence and apply for his first R01.

Public health relevance
PROJECT NARRATIVE Antibodies that stick to and mask the “don’t eat me” signal CD47 activate immune cells against certain blood cancers, but their disappointing performance for solid advanced tumors has spurred a search for complementary biologics to augment anti-CD47 mediated tumor inflammation. CD47-LLO is a novel antibody- drug conjugate that re-engineers the anti-CD47 immunotherapy by fusing it to the bacterial protein Listeriolysin O. Our goal is to optimize its use as a part of a combinatorial therapy strategy to effectively treat multiple aggressive tumors including glioblastoma and metastatic colorectal cancer.